NUTRITION, GI FUNCTION, AND AIDS--ENTERAL FORMULAS FOR NUTRITIONAL SUPPORT

This is an industry supported study to evaluate the potential benefit in AIDS patients of nutritional support using three different commercial enteral preparations.